Expanding HOPE Liver Transplantation: Understanding Opportunistic Infection and Cancer Risk

Early studies of liver transplantation (LT) from donors with HIV to recipients with HIV (HIV D+/R+) under the
HIV Organ Policy Equity (HOPE) Act have shown acceptable transplant outcomes, supporting safety and
feasibility, and prompting the Secretary of Health and Human Services to publish a federal rule to expand this
practice from research-only into clinical care; however, critical knowledge gaps remain regarding some
negative findings. One-year survival in D+/R+ LT was significantly lower (83%) compared to LT from donors
without HIV (D-/R+) (100%). There was also a higher incidence of opportunistic infections (OIs)
(cytomegalovirus [CMV], candida, aspergillus) and viral-associated cancers (Kaposi-Sarcoma associated
herpesvirus [KSHV], human papillomavirus, hepatitis B and C). These early studies were relatively small, and
more data and follow-up time are needed to better understand these risks and measure long-term outcomes.
There are potential virologic and immunologic explanations for higher OI and cancer rates. D+ livers harbor
HIV and HIV D+ are more likely to harbor other viruses as well. Reactivation of these viruses may directly lead
to OIs and cancer; in addition, the viruses may trigger immune activation and inflammation, that impair immune
responses to infections. A better understanding of these pathways can identify interventions to improve
outcomes, such as optimal HIV D+ selection, targeted monitoring, and prophylaxis.
We propose a renewal of our initial HOPE in Action HIV D+/R+ LT U01 grant, entitled Expanding HOPE Liver,
a multicenter study where we will perform 40 HIV D+/R+ LT and 40 D-/R+ LT at 20 transplant centers,
measuring the incidence of OI and cancer. We will combine this new cohort with earlier cohorts (Pilot N=45,
initial U01 N=80), to provide sufficient statistical power for precision and to measure outcomes beyond 5 years.
Within this study, we will perform mechanistic assays to examine virologic and immunologic pathways
underlying OI and cancer. We will characterize prior and active viral infections in donors and recipients with
phage display and immunoprecipitation sequencing, plasma virome molecular studies, and KSHV surveillance.
We will measure immune activation with a multiplexed electrochemiluminescence detection assay for cytokines
and chemokines. We will measure immune responses to CMV and other infections with intracellular cytokine
staining and flow cytometry, and we will use CITE-seq to measure the functional state of immune cells.
Our HOPE in Action Multicenter Consortium has an established track record of conducting multicenter
transplantation trials, including HIV D+/R+ LT. We will expand our existing transplant center network and
leverage existing infrastructure to oversee operations, data management, analysis, and safety monitoring.
In summary, the proposed research will determine the impact of HIV D+ livers on opportunistic infection and
cancer, will quantify long term outcomes, and elucidate mechanisms underlying these complications. This
knowledge can provide a pathway to safely expand HIV D+/R+ LT while improving outcomes.

Public health relevance
Under the HIV Organ Policy Equity (HOPE) Act, livers from donors with HIV can be used for transplants in recipients with HIV (HIV D+/R+). Early studies show that overall outcomes are acceptable and that this practice can decrease waiting times; however, there may be more opportunistic infections and cancers compared to liver transplants from donors without HIV, and long-term outcomes are unknown. In this study, we will quantify any increased risk of opportunistic infection and cancer with HIV D+ livers, 2) measure long term outcomes, and 3) perform scientific studies to understand why infections and cancer develop.